FETAL URINE PRODUCTION AND SWALLOWING RATE--CORRELATION WITH AMNIOTIC FLUID

This study correlates fetal swallowing and fetal urine production with amniotic fluid volume in normal and fluid aberrant pregnancies.